Epithelial type I interferon signaling in Salmonella typhimurium infection

SUMMARY Cytokines are key mediators of inflammation and the host immune response. For many cytokines, signaling cascades are initiated by the binding of cytokines to their cognate receptor and the phosphorylation of Signal Transducers and Activators of Transcription (STAT) proteins by receptor bound Janus kinases (JAK). STAT proteins then form homo or heterodimer complexes, which translocate to the nucleus and regulate the transcription of multiple genes. Despite the high number of cytokines, there are only seven different STAT proteins that determine the fate of cytokine receptor signaling. Type I IFN signaling cascades begin following the binding of IFNα/β to their cognate receptor (IFNAR). IFNAR activation leads to the formation of STAT1/STAT1 homodimers and STAT1/STAT2 heterodimers that each trigger distinct signaling cascades. Animals deficient in STAT1 signaling or IFNAR exhibit defects in inflammasome formation, caspase activation, and inflammatory cell death during infection with S. Typhimurium. However, it remains unclear whether genetic ablation of STAT1/STAT2 signaling alone changes the host response to Salmonella infection. The objectives of this application are to determine the mechanisms by which STAT2 dependent type I interferon signaling in epithelial cells contributes to intestinal inflammation that enables S. Typhimurium to outgrow the microbiota. Our central hypothesis that STAT2-dependent type I IFN signaling in epithelial cells leads to neutrophil recruitment, which in turn creates a microaerophilic and nitrate-rich environment enabling the luminal outgrowth of S. Typhimurium.

Public health relevance
Public Health Relevance Foodborne Salmonella infections are the leading cause of gastroenteritis in the Unites States. Our preliminary data indicate that the transcription factor STAT2 may be central in promoting the outgrowth of Salmonella during infection in the gut. A better understanding of the mechanisms by which S. Typhimurium outgrows competing microbes during inflammation will aid the development of new and innovative approaches for treatment of not only enteric infections. but also inflammatory conditions in which microbial communities are disturbed.